External Research Resources Support and Dissemination Core

Core D - External Research Resources Support and Dissemination The goals of the External Research Resources Support and Dissemination Core of the Michigan NIA P30 Center (MiCDA) are twofold: (1) to support dissemination of research findings by MiCDA affiliates, and (2) to promote research with Michigan-based NIA-supported surveys by investigators outside the UM community. We meet these aims through the following activities. • Editorial and dissemination services: Provide editorial and publication dissemination services for MiCDA networks and affiliates; • Seminars: Support seminars for visiting and local scholars working with Michigan-based data collections on aging research; , • Workshops and Training: Sponsor workshops for new users of Michigan-based NIA-funded surveys and provide technical assistance to other aging-related research studies, with a new focus this cycle on integrating genetics into social science studies. To enhance the former, particularly for users beyond UM, develop a common core curriculum and a set of online, on-demand training videos for working with large panel studies. Through a combination of editorial support, dissemination of working papers, captures and re-posting of media mentions, and the maintenance of nearly comprehensive, fully searchable publication listings for all MiCDA affiliates, Core D highlights and spreads the word about the important research conducted by Michigan's researchers in aging. Core D also promotes the rich resources of NIA-supported surveys by providing opportunities for researchers and scholars to learn about the data - what they encompass, how to gain access, how to best use the datasets - and about the research emanating from the data.

Public health relevance
The External Research Resources Support and Dissemination Core broadly disseminates the results from Michigan's research on the demography and economics of aging, and promotes the use of data collected through NIA-funded Michigan-based studies. In doing so the Core facilitates understanding by a broad audience of the health and wellbeing of older adults in the aging US population and internationally.